Waters Desorption Electrospray (DESI) XS TQ Absolute imaging mass spectrometry system

Abstract
With this proposal, we are requesting funds to acquire a DESI XS Xevo TQ Absolute mass spectrometer from
Waters for bioimaging applications in drug discovery and development at the Sealy Institute for Drug Discovery
(SIDD) at the University of Texas Medical Branch (UTMB). The SIDD capitalizes on UTMB’s world-class
research in infectious disease, neuroscience, and other disciplines for therapeutic development. SIDD
collaborates with academia, industry, government, and philanthropy to pave the way for developing
groundbreaking medicines that enhance and prolong human life. Mass Spectrometry Imaging (MSI) is a
technique for visualizing detailed 2-dimensional maps of drugs, new drug candidates, metabolites, and
biomarkers of disease pathogenesis and efficacious response within biological tissue sections. Therefore,
providing multiple avenues of valuable information supporting discovery including, identification of druggable
targets, adsorption, distribution, metabolism, and excretion (ADME) of drugs and candidate molecules,
biomarker discovery, and therapeutic monitoring. We require this instrument to 1) overcome analytical
limitations in current MSI studies, 2) address the lack of access to MSI technology for all investigators wishing
to use it, and 3) facilitate new MSI projects that are only possible with the analytical advantages offered by the
DESI XS Xevo TQ Absolute. Desorption electrospray (DESI) has unique advantages for MSI including
enhanced metabolite detection and a simple workflow with a lack of intensive sample preparation
requirements. Furthermore, the instrument we are requesting has a tandem quadrupole mass analyzer,
generating targeted MSI datasets with superior sensitivity and selectivity to alternative full scan systems. High
spatial resolution imaging required to visualize analytes within small tissue compartments and cell populations
is made possible due to the sensitivity and rapid image acquisition speeds offered by the instrument. Our
researchers either currently use, or plan to use, MSI for drug discovery and development projects in UTMB
areas of excellence in infectious disease, kidney disease, and neuroscience research. The exceptional MSI
capabilities provided by the DESI XS TQ Absolute will bring unique value to the funded studies described in
this proposal and have the overarching benefit of enhancing drug discovery and development research at
UTMB.

Public health relevance
NARRATIVE The new Waters DESI XS Xevo TQ Absolute imaging mass spectrometer will bring novel molecular bioimaging capabilities in drug discovery and development at the Sealy Institute for Drug Discovery (SIDD) at the University of Texas Medical Branch (UTMB). The instrument will be used to understand drug distribution and identify new drug targets in infectious disease, neuroscience, and kidney disease which will significantly enhance ongoing research projects funded by NIH.